Light Microscopy Core

The Light Microscopy Shared Resource (LMSR) provides state-of-the-art light microscopy technology for fixed
and live cells and tissues, along with scientific and technical expertise to assist in experimental design and
optimal image collection. The LMSR offers affordable and efficient access to 21 instruments with a range of
microscopic technologies, including confocal and conventional fluorescence, multi-photon, lightsheet and super-
resolution to all members of the Duke Cancer Institute (DCI).
Four dedicated, full-time PhD-level staff members provide training, consultation, assistance and full technical
support for all the microscopy systems. DCI members receive special priority access to equipment, training
sessions and staff assistance. Hands-on individualized training and assistance with analysis is provided upon
request to DCI members in advance of other users.
LMSR is supported annually with charge backs from user fees and by the DCI CCSG, the Duke University School
of Medicine and the Duke University Office of Research and Innovation. All standard optical sectioning and
fluorescence microscopy technologies are offered including confocal, resonant scanning confocal, spinning disk,
live-cell imaging with several modalities, long-term incubated time-lapse, multi-photon,
photoactivation/photoconversion and photokinetic capabilities, and in addition, new technologies – super-
resolution point localization and LUMICKS optical trap. Training requests are available on our website and in-
person or remote consultations available. Reservations are executed online through the university-wide software
system on a first-come, first-served basis with some limits to promote efficient use.
LMSR’s continued priority is to serve the light microscopy needs of DCI members with support and assistance
on projects which require light microscopy and image analysis to complete their research. At the same time, we
keep current by examining and testing new and different technologies and strive to implement new technologies
that prove valuable or needed. In fiscal year 2022, LMSR provided services to 235 investigators, 103 of whom
were DCI members, accounting for 44% of total usage, from all seven DCI Research Programs.